STUDY OF DRUG RSVIG-IV TO PROTECT CHILDREN WITH BRONCHOPULMONARY DYSPLASIA

The objective of this study is to evaluate the safety and efficacy of intravenous RSV immunoglobulin infusions given monthly during the RSV season to reduce the rate of RSV hospitalizations in premature infants and infants with bronchopulmonary dysplasia.